Core 1: PRACTICE Shared Resource Core

PROJECT SUMMARY: PRACTICE SHARED RESOURCE CORE
The proposed Population Research And Clinical Trials In Cancer Equity (PRACTICE) Shared Resource Core
will build upon the infrastructure of the existing Clinical Trials Core (CTC) that has provided support to the
Meharry/Vanderbilt-Ingram Cancer Center/Tennessee State Cancer Partnership (MVTCP) since its
inception. While the CTC has been instrumental in bringing clinical trials to the patient base at Nashville
General Hospital (NGH) at Meharry Medical College (MMC), to more completely address cancer health
disparities, we must augment these efforts with studies in prevention, early detection, treatment,
survivorship and palliative care in the Nashville Metropolitan Statistical Area (MSA), served by our
Partnership. We propose to establish the PRACTICE Shared Resource Core to further benefit the NGH
patient base, promote investigator-initiated research and extend the Partnership's reach to the underserved
in the Nashville MSA. The MVTCP has great strength in population sciences research that will enhance the
existing strength in clinical research. Examples include studies led by MMC, Tennessee State University
and Vanderbilt-Ingram Cancer Center (VICC) investigators working with statewide cancer registries to recruit
for etiologic studies of breast cancer, lung cancer screening trials for early detection, a tobacco control trial in
the underserved, enhancing participant recruitment to cancer research and collection of biospecimens in
collaboration with the Cancer Outreach Core and Translational Pathology Shared Resource Core. There is a
rich history of conducting therapeutic clinical trials with interactions between the Clinical Trials Office (CTO) at
VICC and the CTO at NGH. The overarching mission of the PRACTICE Shared Resource Core is to enhance
accrual to therapeutic clinical trials while expanding access for minority and underserved patients to research
studies across the cancer care continuum. The PRACTICE Core worked extensively with Lucy Spalluto, MD
in the genesis of her proposed project examining the implementation of breast cancer risk assessment in
underserved women. We will assist with implementation of this study and dissemination of the results. Our Core
will also support other clinical and population-based science research across the cancer care continuum,
illustrated in three thematic domains focused on decreasing cancer health disparities: prevention and early
detection; interventional trials and observational studies during and following treatment; implementation of
healthcare interventions to improve cancer care delivery. The PRACTICE Core will address the following aims:
1) expand the portfolio of therapeutic clinical trials and cancer control studies relevant to the patient base of
NGH at Meharry and the Nashville MSA; 2) develop a cancer cohort at NGH at Meharry to serve as a resource
for future studies across the cancer care continuum; and 3) provide training and mentorship for clinical trainees
in the conduct of clinical trials and in the recruitment and retention of underserved populations in research.